Access to and Choice of VA or Non-VA Health Care by Veterans of Recent Conflicts

Background: This CDA will provide me, Megan E. Vanneman, PhD, MPH, with the training and
experience to become an independent health services researcher who applies decision science and
informatics to improve Veterans’ access to and engagement in high-quality care. To help achieve this goal, I
will work with my mentors, consultants, and operational partners to develop and evaluate an information and
decision support tool to improve VA leaders’ understanding and decision-making about VA enrollment and
reliance (proportion of care received at VA) on primary and mental health care.
Significance/Impact: This research will have a positive impact on VA leaders, Veterans interested in
enrolling in VA health care, and Veterans needing primary and mental health care, by increasing
understanding of how access, quality, enrollment, and reliance can be optimized to better meet Veterans’
needs. As the VA moves from a more closed, integrated healthcare system to providing care through networks
that include community partners, VA leaders need to better understand enrollment, reliance, access, and
quality at their local facilities and VISNs, particularly for “foundational services,” such as primary and mental
health care. The CDA strongly aligns with top VA priorities – increasing choice for Veterans, modernizing the
VA system, using VA resources more efficiently, and improving timeliness of services.
Innovation: While we know that about 50% of Veterans enroll in VA and that about 50% of care for these
enrollees is provided in the VA, we have little understanding of what drives these decisions for recently
separated Servicemembers – those who participated in conflicts in Iraq and Afghanistan. Preliminary studies
show that there is wide variation in VA facility enrollment rates, but we do not have data on variation in VA
facility reliance rates. Furthermore, we do not understand what drives these differences. Although there is
some understanding of individual (e.g., age) and community-level (e.g., non-VA provider supply) factors that
influence VA enrollment and utilization, we lack understanding of facility factors that can be modified to
appropriately connect Veterans to VA and needed services thereafter.
Specific Aims: The research plan has three primary goals: 1) Learn what information and resources VA
facility and VISN leaders need to better understand and manage enrollment rates and reliance rates for
primary and mental health care; 2) Derive insights on facility factors by evaluating relationships among
enrollment rates, reliance rates, access to care, and quality of care for primary and mental health care; and 3)
Develop or modify existing information tool(s) to assist facility and VISN leaders to manage enrollment and
reliance rates for primary and mental health care.
Methodology: This CDA seeks to fill the gap in understanding on enrollment and reliance for primary and
mental health care through a mixed-methods approach by: producing descriptive data on facility enrollment
and reliance rates (Aim 1.1); qualitatively studying Veterans’ insights on their decisions regarding enrollment
and reliance in interviews involving VA enrollees and non-enrollees (Aim 1.2); interviewing VA leaders about
their information needs regarding enrollment and reliance (Aim 1.3); using hierarchical modeling to understand
what modifiable facility factors on access and quality are associated with enrollment and reliance rates (Aim 2);
and developing, testing, and implementing a tool to assist VA leaders to improve enrollment and reliance rates
(Aim 3).
Next Steps/Implementation: Study results will help VA healthcare leadership target changes that they
can make to manage enrollment and retention of Veterans in the VA healthcare system and deliver needed
foundational services. Results will also inform my future work on information and resource allocation tools to
support Veterans’ and leaders’ decision making.

Public health relevance
Iraq and Afghanistan Veterans have higher rates of mental health conditions than other Servicemembers, perhaps related to longer and more frequent deployments. Given the overall high quality of mental health care provided at the VA, it is critical to understand why we see vast differences in enrollment rates in VA medical centers across the country as well as variability in engagement in care. As options for health care outside the VA have recently increased for this population, primarily though the Affordable Care Act’s Medicaid expansion, VA’s Choice Act and VA’s MISSION Act, Veterans’ health care has become more fragmented. To ensure that Veterans have access to high-quality integrated primary and mental health care, VA leaders need currently unavailable information to better understand enrollment and utilization patterns at their local facilities and regions. I propose to develop information and decision support tools to improve their understanding of and ability to impact VA enrollment and engagement in primary and mental health care.